MKK4 Regulation of Liver Regeneration after Resection of Colorectal Metastasis or Hilar Cholangiocarcinoma

PROJECT SUMMARY
The extent of resection and size of the functional liver remnant after major hepatectomy for liver cancer are major
factors affecting patient outcome and risk of post-hepatectomy liver failure. Therefore, therapies that stimulate
liver regeneration without increasing the risk of tumor growth are vital to improving outcomes. Preliminary work
by our German collaborators identified the dual-specific MAP2 kinase MKK4 as a master regulator of hepatocytic
regeneration. In collaboration, we have identified a novel compound, HRX215, a highly selective small molecule
MKK4 inhibitor with favorable pharmacokinetics that induced striking liver regeneration after partial hepatectomy
in murine and porcine models of acute liver damage. Based on these favorable preclinical data, we hypothesize
that HRX215 can promote liver regeneration in human patients. In the proposed phase 2b clinical trial, we will
examine the effects of HRX215 in human patients receiving major hepatectomy at a single center, Mayo Clinic,
Rochester, MN. In Aim 1, eighty patients undergoing portal vein embolization before major hepatectomy for
colorectal cancer liver metastases will be randomized equally into treatment or control groups. Treatment
patients will be administered 250 mg (PO) HRX215 twice daily for 28 days, initiated 12 hours before portal vein
embolization. Control patients will receive a placebo. All patients will undergo volumetric computed tomography
(CT) scanning before and on day 7 and day 28 after portal vein embolization. We hypothesize that the functional
liver remnant in treatment patients receiving HRX215 will experience greater volumetric gain (indicating faster
regeneration), and allow resection earlier and in a higher percentage of patients compared to the control group.
In Aim 2, 40 patients undergoing major hepatectomy for hilar cholangiocarcinoma will be randomized equally
into control and treatment groups, with control patients receiving a placebo and treatment patients receiving 250
mg (PO) HRX215 twice daily for 28 days following surgery. Both groups of cholangiocarcinoma patients will
receive standard care, with volumetric CT scanning performed before and on day 7 and day 28 after resection.
We hypothesize that patients administered HRX215 will have faster volumetric gain and reduced incidence of
post-hepatectomy liver failure compared to control patients. Finally, we will use blood and tissue samples to
measure intrahepatic neutrophil accumulation, quantify circulating myeloperoxidase and inflammatory factors,
and perform spatial transcriptomics on the regenerating liver. These data will be used to determine the predictive
value of novel blood and intrahepatic tissue markers in determining outcomes after surgery and estimating the
risk of PHLF. We hypothesize that HRX215 will reduce post-resection inflammation and this response will
correlate with better clinical outcomes. We believe these human trials could lead to new treatments for patients
receiving major hepatectomy and identify a novel drug target for enhancement of liver regeneration.

Public health relevance
PROJECT NARRATIVE Surgical resection remains the primary curative treatment for liver cancer, a major health problem in the United States. HRX215 is a novel first-in-class drug with properties that have allowed the liver to recover more quickly and successfully after tumor resection in animal models. The current study will determine if HRX215 has similar properties in humans, allowing larger liver tumors to be removed safely and with a reduced risk of liver failure.